Development of large-scale composite null hypothesis testing approaches to perform translational genetics analyses

Abstract/Project Summary
Germline genetics research often relies heavily on large-scale hypothesis testing to detect associations
between complex traits and their risk mutations. Traditionally, the statistical methods that we and others have
developed for these settings have focused on powerful approaches that test global null hypotheses - identifying
the existence of any signal in a set of individual tests. In recent years though, researchers have also
increasingly emphasized novel study designs that are more suitable for another class of tests known as
composite null hypothesis tests. Roughly speaking, the goal of a composite null hypothesis test is to identify
the existence of multiple, as opposed to at least one, signal in a set of individual tests. However, the lack of
validated variants identified by composite null analyses belies the high popularity of such studies, suggesting a
lack of suitable quantitative approaches. The central goal of this proposal is to develop high-dimensional
composite null hypothesis testing approaches that (a) provide interpretable results addressing the scientific
question of interest and (b) offer robust performance over varied genome-wide settings. Specifically, one study
design of interest is (i) pleiotropy studies. A common goal in performing pleiotropy analysis is to identify
variants linked to multiple diseases simultaneously, which may, for example, suggest new indications for
existing therapies. Many existing pleiotropy approaches test global nulls, which are still applicable but often
less pertinent. Another related study type is (ii) mediation analysis. When testing for genetic mediation, interest
lies in the simultaneous associations of a variant to a mediator and the mediator to an outcome. Thus, a
composite null approach that identifies at least two associations is more suitable for this type of investigation.
Additionally, (iii) replication studies are ubiquitous in genetics research and require more than one association
to declare a successful replicated effect. We will develop approaches that leverage our existing empirical
Bayes tools to perform composite null inference in (i)-(iii). Different models will be proposed to address unique
statistical challenges such as the within-set correlation that arises in (ii) and directionality restrictions in (iii).
Extensive simulation studies and real data examples will be used to illustrate (a) and (b), as well as
demonstrate advantages over global null interpretations. Successful completion of this work will result in novel,
interpretable, and robust strategies to perform large-scale pleiotropy, mediation, replication, and other
translational genetics studies across a variety of phenotypes. We will also develop well-documented, publicly
available software packages to share this methodology with the research community. Summary data from
analysis of varied phenotypes will be released.

Public health relevance
Narrative Many increasingly popular study designs in genetic association studies require large-scale hypothesis testing on non-standard hypotheses known as composite null hypotheses. For example, such testing is used to find genetic variants with pleiotropic, mediated, and replicated effects, however the number of validated discoveries remains low relative to the frequency of the investigations. We will develop new methods to perform composite null inference in a robust and interpretable manner, and we will demonstrate the potential of our approaches through application across varied traits.